Heterozygous KMT2D Loss and Medulloblastoma

PROJECT SUMMARY
Medulloblastoma (MB) is the most common malignant primary brain tumor in children. MB is frequently induced
by the alterations of cellular signaling pathways, such as sonic hedgehog and wingless pathways, which have
been extensively characterized. Nevertheless, current treatment of MB causes severe life-long side effects and
fails to cure many patients. Thus, there is an unmet need for a new mechanistic understanding that would be
helpful for designing a mechanism-based approach for MB treatment. Epigenetic aberrations, which are heritable
aberrations in gene expression or cellular phenotypes without accompanying changes in DNA sequences, are a
major factor for tumorigenesis. Epigenetic modifiers often harbor DNA alterations, such as mutations and
deletions, in human MB. However, the roles of epigenetic modifiers in MB development remain largely unknown.
Histone lysine methylation, a type of histone posttranslational modification, is a hallmark of epigenetic and
transcriptional regulation of gene expression and is reversibly modified by histone methyltransferases and
demethylases. Of histone lysine methylation, methylations at histone H3 lysine 4 (H3K4) are key gene-activating
epigenomic marks. For example, monomethyl H3K4 is a mark for enhancers, which activate genes by interacting
with gene promoters. In addition, trimethyl H3K4 occupies as much as 75 % of all human gene-regulatory regions,
and broad trimethyl H3K4 is a gene-activating signature that denotes tumor suppressor and cell identity genes.
We have previously reported that the H3K4 methyltransferase KMT2D (also called MLL4, ALR, and MLL2; a
transcriptional coactivator) is required for retinoic acid-induced neuronal differentiation of human neuron-lineage
NT2/D1 stem cells. Notably, our other study showed that homozygous loss of Kmt2d in the mouse brain
developed spontaneous MB in the cerebellum, a brain region that controls motor coordination and balance.
Strikingly, our additional results showed that heterozygous loss (single-allelic) of Kmt2d highly promoted MB.
Based on these compelling findings, our long-term goal is to define the oncogenic role of heterozygous loss of
Kmt2d in MB pathogenesis. Our central hypothesis is that heterozygous loss of Kmt2d causes epigenomic
alterations to downregulate tumor suppressor genes and thereby promotes MB. Here, we propose to study to 1)
characterize the MB-promoting effect of heterozygous Kmt2d loss using genetically engineered mouse models;
2) define the molecular mechanism by which heterozygous Kmt2d loss promotes MB; and 3) determine how
heterozygous Kmt2d loss causes epigenomic alterations. Because KMT2D is one of the most frequently mutated
genes in MB and a majority of KMT2D mutations in MB are heterozygous and truncations, our proposed studies
are significant and clinically relevant. In addition, our studies using genetically engineered mouse models will
define an in vivo MB-promoting role for heterozygous Kmt2d loss. Furthermore, our results will uncover the
previously unappreciated epigenetic mechanism underlying MB pathogenesis and provide valuable information
for the rational design of a therapeutic approach for MB treatment.

Public health relevance
PROJECT NARRATIVE The proposed studies are designed to define the in vivo pathogenic role of heterozygous loss of the epigenetic modifier KMT2D in medulloblastoma genesis using mouse models and to provide epigenetic and mechanistic insights into how heterozygous KMT2D loss promotes medulloblastoma. Because KMT2D is one of the most frequently mutated genes in human medulloblastoma and a majority of KMT2D mutations are heterozygous, our epigenetic and mechanistic findings from the proposed studies will be fundamental to a better understanding of the molecular basis of human medulloblastoma and be beneficial for development of a strategy for therapeutic intervention of human medulloblastoma.